Lifespan extension, Somatotropic signaling and Tauopathy

Tauopathies are a class of neurodegenerative diseases characterized by accumulation of
abnormal and hyperphosphorylated tau protein in the brain including Alzheimer's disease (AD),
Parkinson's disease (PD), Frontotemporal dementia (FTD), and Motor Neuron Disease (MND).
Tauopathies occur primarily in elderly population and incidence rises with increasing age.
Unfortunately, the mechanisms for the age-dependent onset of tauopathies are unknown and
there are no effective therapeutic strategy. Aging is the biggest risk factor for tauopathies
related disorders, suggesting that molecular alterations contributing to the aging process may
represent common mechanisms for tau pathology. Employing the pathways that could slow or
delay the aging process may offer novel targets for new therapeutic strategies.
Murine mutant mice with slow rates of aging and murine tauopathy models with varying
phenotypic effects provide the opportunity to develop novel genetic models that will allow
studying the interaction of aging and tauopathy. Our proposal is to elucidate the role of the
somatotropic axis in the age-dependent susceptibility to tauopathies. Our study will generate
new models to study the interaction of aging with neurodegenerative diseases in the context of
mutations that slow the aging process.

Public health relevance
PROJECT NARRATIVE The proposed research is aim to address a crucial public health issue in a cost-effective manner because the aging of the Baby Boomer generation is resulting in a massive increase in the absolute number and proportion of elderly Americans. Metabolic impairment is the biggest risk factor for many diseases, leading to increased cost of healthcare. This project will develop new models to study hormonal signaling, cognitive aging and neurodegenerative diseases, and serve as a foundation for promising novel approach for the development of counter-neurodegenerative therapy.